Path C Oklahoma Department of Agriculture, Food, and Forestry Cooperative Agreement Program with FDA to Implement a National Produce Safety Program

Funding Opportunity PAR-21-174
Oklahoma Department of Agriculture, Food, and Forestry
Project Summary
The Oklahoma Department of Agriculture, Food, and Forestry proposes to continue our
state Produce Safety Program to encourage the safe production of fresh fruits and vegetables
and to promote compliance with the requirements of FDA’s Regulation “Standards for the
Growing, Harvesting, Packing, and Holding of Produce for Human Consumption.”
In order to accomplish this goal, we plan to: assess our produce farm landscape,
establish a process to develop and maintain a produce farm inventory, develop and support the
program’s infrastructure, formulate a multi-year plan, identify and collaborate with industry
and educational partners, provide education and technical assistance to farming operations,
perform outreach to inform the industry of the produce safety rule, build a complete farm
inventory, inspect covered non-exempt farms for compliance with the produce safety rule,
track and report aggregate data on program activities and inspections, and assess our ability to
respond to a produce-related event/incident.
The accomplishment of this goal will advance efforts for a nationally integrated food
safety system by having the state produce safety program align with the FDA produce safety
program. The funds that are made available through this cooperative agreement will allow our
agency to implement multi-year, strategic plans to ensure continuous improvement and
demonstrate we are moving towards the goals of improved produce safety and high rates of
compliance with the Produce Safety Rule. Without the funds being made available through this
funding opportunity our agency would be unable to undertake any part of attaining this goal.
We are applying for grant Path C, as our state has authority to inspect and enforce
compliance on produce farms for any federal program as listed in the Oklahoma State Board of
Agriculture Powers of the Board in Oklahoma Statutes §2-2-4 #34
(http://webserver1.lsb.state.ok.us/OK_Statutes/CompleteTitles/os2.rtf). Using this statute, we
promulgated rules to adopt the FDA’s Produce Safety Rule (21 CFR Part 112) in its entirety, as
can be found in Oklahoma Administrative Code Title 35, Chapter 37, Subchapter 17:
http://www.oar.state.ok.us/oar/codedoc02.nsf/All/E5747A97BE28EE9B86258602004B3563?O
penDocument. We also intend to conduct joint inspections with FDA of sprout farms.

Public health relevance
Funding Opportunity PAR-21-174 Oklahoma Department of Agriculture, Food, and Forestry Project Narrative The Oklahoma Department of Agriculture, Food, and Forestry will be able to reduce the potential threat to public health from ready-to-eat fruit and vegetables by developing, implementing and maintaining an Oklahoma Produce Safety Program that is in alignment with the FDA Regulation “Standards for the Growing, Harvesting, Packing and Holding of Produce for Human Consumption,” otherwise known as the Produce Safety Rule. This program will provide outreach to growers of ready-to-eat fruits and vegetables to educate and provide guidance concerning food safety issues associated with the growing of ready-to-eat produce and the regulatory requirements of the Produce Safety Rule. This combination of outreach and regulatory oversight should significantly reduce the risk of foodborne illness associated with the consumption of ready-to-eat produce.